MECHANISMS OF AUTOANTIBODY PRODUCTION IN SLE AND RELATED AUTOIMMUNE DISORDERS

In this study, the causes of antinuclear antibodies will be investigated using the serum and white blood cells of patients with lupus and other forms of autoimmune disease.